NEW MACROCYCLIC LIGANDS FOR CHELATING LANTHANIDE

We are developing new macrocyclic ligands with complex lanthanides for various biomedical applications. FAB mass spectrometry is required to verify the exact molecular weight of each cyclic amine precursor.